Imaging/Histopathology (I/H) Core

Project Summary (Imaging/Histopathology)
Continuing funds are requested by 17 vision scientists (holding 13 eligible NEI R01 grants) and
their personnel to support three resource/service cores and an administrative core in the newly
merged Department of Ophthalmology, Visual and Anatomical Sciences (former Ophthalmology
and Anatomy/Cell Biology Departments). The Imaging/Histopathology (I/H Core) will be directed
by Dr. Ryan Thummel, an R01-funded investigator with significant imaging expertise. Together
with the PI, and two research assistants, the environment and capability to conduct vision
research at Wayne State University and affiliated institutions will be enhanced through
prioritization of the work of NEI R01 funded investigators, their staff and students (graduate and
fellows) in numerous aspects of Imaging and Histopathology. The I/H core, located in Scott Hall
and readily accessible to vision scientists, will provide for visual function analysis, embedding,
sectioning/cryosectioning and immunostaining of tissues, for confocal laser scanning, light
microscopy, immunofluorescence, OCT and other cell imaging analyses (e.g., cell viability and
quantification of plasma membrane potential), and train in equipment use. The I/H Core will
foster collaboration among NEI R01 funded investigators primarily and at reduced priority for
unfunded colleagues. Clinical and translational studies also will be fostered between NEI R01
funded investigators and clinicians in the newly merged department (OVAS). The I/H Core also
will support, at reduced priority, new investigators, and/or others (e.g., those who are seeking
new research directions) or who are collecting preliminary data to be used for NEI R01 grant
submission.